Mechanisms of opioid- mediated HIV neuropathogenesis

This proposal is to examine molecular mechanisms of HIV-mediated neuroinflammation in the presence of
ART and opiods. We will use morphine as it exacerbates inflammation and CNS disease in many HIV infected
people. HIV infection of the CNS results in chronic inflammation that leads to cognitive deficits in > 50% of
infected people. This inflammation and subsequent CNS damage is not mitigated with ART. Inflammation is a
key process in HIV disease and therapies to limit this and ongoing CNS viral seeding must be developed to
improve the quality of life of infected people. This is even more pressing as HIV positive people live longer. HIV
enters the CNS soon after peripheral infection and despite ART, persists within infected cells. HIV entry into
the brain is mediated, at least in part, by infected monocyte transmigration across the blood brain barrier
(BBB). Mature monocytes expressing CD14 and CD16 are key mediators of HIV neuropathogenesis. These
monocytes are productively infected with HIV and primed to cross the BBB. Once within the CNS, they may
differentiate into infected macrophages that can persist for years. This leads to infection and/or activation of
CNS cells, including macrophages and microglia, resulting in chronic inflammation characterized by production
of virus and/or viral proteins, and cytokines, and chemokines. Chemokines, in particular CCL2, increase
transmigration of peripheral blood infected/uninfected monocytes, continuing inflammation and viral seeding of
the CNS that mediates neuronal dendritic pruning and degeneration in a large number of infected people by
mechanisms not well understood. ART does not eliminate cells harboring HIV. Thus, monocyte/macrophage
activation, and production of HIV early proteins continue, resulting in brain injury despite successful ART. We
will characterize effects of morphine, HIV, and ART on mechanisms that mediate monocyte entry into the CNS
and on subsequent viral reseeding and neuroinflammation. We will use state of the art in vitro techniques, the
powerful approach of single cell RNA sequencing, and transgenic mice to characterize potential therapeutics to
limit inflammation and guide efficacy of ART. We will characterize the impact of morphine and ART on
transmigration of HIV infected and uninfected human monocytes across a model of the human BBB and use
scRNA-seq to identify unique genes expressed by individual transmigrating HIV-infected and HIV-exposed
monocytes in the presence or absence of morphine; characterize the impact of HIV, ART, and/or morphine on
the function of human macrophages and, using scRNA-seq, on expression of inflammatory genes by individual
human macrophages; apply an HIV transgenic mouse model to evaluate the in vivo impact of opioids and HIV
on inflammatory genes expressed in vivo by individual monocytes from the mice that transmigrated across the
BBB, and by resident individual brain macrophages/microglia from these mice; and compare expression of
inflammatory genes by individual macrophages/microglia isolated from the brains of HIV-naïve and HIV-
infected individuals including those from people who were on palliative opioid treatment using scRNA-seq.

Public health relevance
HIV infection of the brain results in chronic inflammation that leads to cognitive deficits in more than 50% of infected people. Substance abuse exacerbates neuroinflammation in many HIV infected people. This inflammation and subsequent CNS damage is not mitigated with antiretroviral therapy (ART). Thus, inflammation is a key process in HIV disease and therapies to limit immune activation and inflammation must be developed to improve the quality of life of HIV infected people. This is an even more pressing need as HIV positive individuals live longer. The goal of this proposal is to examine molecular mechanisms of HIV-mediated inflammation in the presence ART and opiods to enable the development of such interventional strategies.